Administrative Core-Biomarkers for optimizing risk prediction and early detection of cancers of the colon and esophagus

PROJECT SUMMARY
The Administrative Core (AC) of our Biomarker Characterization Center (BCC) will facilitate and optimize
the integration of biomarker discovery and initial validation studies by the Biomarker Discovery Lab (BDL) and
the development and validation studies to create clinical-grade, CLIA compliant biomarker assays by the
Biomarker Reference Lab (BRL). The Administrative Core will be managed by the Center Administrator and run
by the PIs of the BDL and BRL. It will support and enhance cross BCC and cross EDRN communication, data
dissemination and data review and analysis, which will promote the BCC’s core mission to discovery and validate
clinical grade biomarker assays for GI cancer risk prediction and early detection The Administrative Core will
provide administrative support for collaborations and communications between the EDRN BCCs, Clinical
Validation Centers (CVCs), Data Management Center (DMCC); collaborating industrial partners (e.g. Cernostics,
Qiagen, etc.) and academic partners, and collaborating NCI programs (e.g. CISNET, NIST, etc.). Through the
functions of the Administrative Core, the BCC with other EDRN BCCs, CVC, and DMCC, industrial partners, and
academic partners will collaborate not only on the BCC’s studies but also on resulting derivative studies and
other EDRN BCC and CVC projects that arise from the BCC’s highly innovative, productive and significant
program of biomarker discovery and validation for GI cancer risk prediction and early detection and the programs
of other BCCs.
The Administrative Core has the following aims:
Aim 1: To provide the organizational structure for supporting the key objectives of the BCC, which are the BDL’s
and BRL’s scientific and educational missions and the successful collaboration among the BDL and BRL PI and
scientists, EDRN partners, academic partners and industrial partners.
Aim 2: To provide efficiency in management of large-scale collaborative research efforts involving multiple
institutions and multiple PDs/PIs, including local and national meetings management.
Aim 3: To coordinate with EDRN DMCC for protocol development, biospecimen sharing, biospecimen blinding,
data analysis, data sharing, data deposition, populating Biomarker Data Commons, and any other relevant
functions deemed necessary for BCC operations as well as for the larger Network.